Roles of microRNAs in animal development

Project Summary
The long-term goal of our lab is to understand gene regulatory mechanisms that enable the development of a
single cell zygote into a multicellular organism. This proposal focuses on an essential mechanism in all
animals, the post-transcriptional repression by microRNAs. MicroRNAs (miRNAs) repress target genes,
controlling their protein output in time and space. They provide an essential layer of regulation during
development, evidenced in the fact that loss of the machinery that processes these short RNAs causes
embryonic lethality in every animal examined. Moreover, mutations in the miRNA biogenesis or effector
machinery in humans causes syndromic diseases. Individual miRNAs have also been linked to essential
functions in model organisms as well as disease in humans (e.g. mutation in a single miRNA causes
progressive deafness in humans). Although the number of miRNAs has increased during animal evolution, a
set of 32 miRNAs were present in the last common ancestor of bilaterian animals and have been conserved
over hundreds of millions of years. However, with few exceptions, the functional targets of these highly
conserved miRNAs remain unknown due to a number of technical challenges associated with: i) the short
nature of miRNAs that has made their profiling more difficult than longer mRNAs, ii) the fact that miRNAs exert
quantitative, often modest, repression on their targets, and iii) the fact that target predictions that largely rely on
short sequence information, produce an excess of false positives.
Our research program systematically tackles the roles of conserved miRNAs during animal development. We
have developed a research strategy that leverages the experimental system provided by C. elegans, with
state-of-the-art molecular biology and genetics approaches. The strategy we have outlined will yield knowledge
on the functions of these important regulators at the organismal and cellular level and will bridge that with a
deep understanding of molecular mechanism based on our strong focus on identifying functionally critical
targets. Knowledge of these targets has allowed us to begin to address how changes in their dosage, even if
modest, affect cellular processes and ultimately development and physiology. Our findings in C. elegans are
also guiding investigation of these conserved miRNAs in mammalian cell models. Our work will reveal the
functions of essential, conserved miRNA genes and will uncover cellular pathways for which dosage control is
important. We anticipate that this knowledge will be important to interpret mechanisms of human disease.

Public health relevance
Project Narrative MicroRNAs are regulatory RNAs that control the level of expression of target genes. Loss of miRNA-mediated regulation in humans causes diseases that range from deafness upon loss of a single miRNA, to complex syndromes when miRNA production as a whole is affected. The work proposed here seeks to identify the targets and functions of miRNAs that are highly conserved across animals.